Mechanisms of Neurodegeneration in CMT4B3: a Complex Pediatric Neurodevelopmental Disorder

Charcot-Marie-Tooth Disease type 4B3 (CMT4B3) is a rare, autosomal recessive hereditary
axonal neuropathy, often presenting with severe regression of developmental milestones during infancy
or early childhood. CMT4B3 has a wide clinical spectrum of symptoms. It ranges from an isolated
demyelinating sensorimotor polyneuropathy to a complex neurodevelopmental phenotype with axonal
neuropathy, cranial nerve involvement, intellectual disability and facial dysmorphism. Most children
affected by CMT4B3 present with the severe phenotype. CMT4B3 is caused by mutations in the Sbf1
gene, resulting in disrupted function of the pseudo-inositol phosphatase, Myotubularin-Related Protein
5 (MTMR5). In this proposal, we focus on MTMR5, a developmentally important regulator of autophagy
and endo-lysosomal trafficking, and its involvement in proper axonal homeostasis.
MTMR5 is known to catalytically regulate and dictate the subcellular localization of Myotubularin-
Related Protein 2 (MTMR2), an active phosphatase against phosphatidylinositol species. MTMR2 has
known roles in Schwann cell homeostasis and loss of MTMR2 leads to a demyelinating neuropathy.
MTMR5 was also identified as a neuron-specific suppressor of autophagy. Despite this knowledge, it
is entirely unknown how disrupted function of MTMR5 leads to axonal degeneration during early
childhood. Through the aims of this fellowship and using an established iPSC-derived motor neuron
model of CMT4B3, I seek to clarify the biochemical role of MTMR5 in motor neurons and how loss of
normal MTMR5 function results in axon degeneration early in development. In Aim 1 of this fellowship,
I propose to utilize an iPSC-derived motor neuron model of CMT4B3 to understand the effects of
MTMR5 loss on MTMR2, MTMR13, and phosphoinositide levels and discriminate if residual MTMR5
function causes toxicity in axons. In Aim 2, I seek to l gene expression profiling to characterize the
downstream defects as a result of MTMR5 loss, which likely stem from MTMR5’s role in autophagy and
endo-lysosomal trafficking. I plan to develop high-content image-based analyses to confirm expression
profiling results and to create a much needed platform for drug discovery and gene therapy validation.
Fully understanding the mechanisms underlying CMT4B3 is critical to the NICHD mission. Such
knowledge is crucial for development and proper evaluation of therapeutic modalities that could help
CMT4B3 patients. With this perspective, the proposed project is tailored to my training towards
becoming a translational pediatric neurologist and scientist.

Public health relevance
Charcot-Marie-Tooth Disease Type 4B3 is a devastating complex axonal neuropathy which onsets very early in life and features neurodevelopmental delay, central nervous system involvement and musculoskeletal defects. The gene responsible for CMT4B3 is Sbf1, which encodes Myotubularin- Related Protein 5, a hypothesized regulator of endo-lysosomal trafficking and autophagy in neurons, two processes that are critical in early development. This project will therefore examine the specific molecular mechanisms of axon degeneration in Charcot-Marie-Tooth Disease Type 4B3 due to mutations in MTMR5 and will seek to identify robust cellular phenotypes that can be used for identification of therapeutic targets and genetic therapy validation.